CCSG Supplement: Strengthen the Research, Training, and Outreach Capacity

P30 Administrative Supplement to The University of Texas MD Anderson Cancer Center’s “Cancer
Center Support Grant” (P30 CA016672 47, Principal Investigator: Peter T. Pisters, MD)
PROJECT SUMMARY: This supplement proposes the implementation of a collaborative training program to
connect underrepresented minority scholars with training navigators. Training navigators will help connect
scholars to the Continuing Umbrella of Research Experiences (CURE) program. Our goals for this supplement
funding period are to fund scholars’ career development activities, workshops, conferences, and certificates.
Combining the rich resources of MD Anderson, the aims of this supplement are to: 1) Identify
underrepresented minority scholars (predoctoral, postdoctoral fellows, or early-stage investigators); 2) Engage
and provide training support to scholars; and 3) Leverage two existing TNs with expertise in career
development and grant administration and hire a third TN with expertise in cancer health disparities and
connection to CURE and Region 3 GMaP research, training, and funding opportunities.
RELEVANCE: This supplement proposes the implementation and completion of a Training Navigation
program, which will provide hands-on support to assist predoctoral and postdoctoral fellows and early-stage
investigators with their educational advancement and career development activities.

Public health relevance
PROJECT NARRATIVE: OVERVIEW Cancer affects 1 in every 3 people in the US and as our population ages this fraction is expected to increase. Outcomes for cancer patients have improved over the last several decades, but there is still a great burden of cancer-related mortality and morbidity that is borne disproportionately by minorities and the economically disadvantaged. MD Anderson Cancer Center's mission is to eliminate cancer in Texas, the nation and the world through outstanding programs that integrate patient care, research and prevention, and through education for undergraduate and graduate students, trainees, professionals, employees and the public. Our vision is to be the premier cancer center in the world based on the excellence of our people, our research-driven patient care and our science.